Admin Core

NEVADA STATE PUBLIC HEALTH LABORATORY ADM CORE ABSTRACT The Nevada State Public Health Laboratory (NSPHL) is Nevada’s only public food provides a wide range of diagnostic and analytical services for the assessment and surveillance of infectious/communicable diseases, foodborne outbreak analyses, radiological testing (in development), biological and chemical terrorism analyses and the analytical evaluation of water to evaluate safety for consumption and compliance throughout Nevada. testing laboratory and The NSPHL is accredited/licensed by various agencies for human and environmental testing: CLIA, College of American Pathologists (CAP), EPA and LRN. The NSPHL has formulated a management team to oversee all aspects of testing at the State Lab in compliance with ISO/IEC 17025:2017 Standards. The Laboratory Director and Administrative Director/Laboratory Manager of the NSPHL oversee all testing activities in the different divisions of the laboratory. In addition, a Quality Manager and Biosafety Officer were added to the management team to assure broad expertise, staff competency, result quality and safety oversight. The NSPHL has been working toward ISO/IEC 17025:2017 Accreditation. The initial accreditation inspection is scheduled for July 23-24, 2020 to be conducted by A2LA. An overarching Quality Management System is and will continue to be maintained as well as equipment to support the staff in performing existing Manufactured Food Regulatory Program (MFRP) and foodborne illness outbreak testing. Through the application of additional projects, it is desired that the existing food testing capabilities at the NSPHL be expanded to include more analytical methods to comply with The Food Safety Modernization Act (FSMA) ultimately providing risk-informed food safety strategies with foodborne illness prevention in mind. Page 1 of 1